STORAGE OF NUMOM2B FETAL DNA ALIQUOTS FROM CORD BLOOD FOR THE PREGNANCY AND PERINATOLOGY BRANCH OF NICHD

The NuMoM2b study was a prospective observational study of over 10,000 nulliparous women followed from the first trimester through delivery to understand the mechanism and etiology of adverse pregnancy outcomes starting in the first trimester. It was conducted at eight clinical sites. All study participants underwent serial evaluations including demographics, nutrition, family history, maternal anthropometric measurements, medical history, assessments of psychosocial factors, ultrasound measures of fetal growth, placental function (uterine artery Doppler) and biospecimen collection (maternal serum, plasma, urine, cervical/vaginal samples, placenta at delivery). Dr. Haas of Indiana University will purify DNA from the cord blood specimens from each participant in the NuMom2b study. At his expense he will receive shipment of and generate DNA from approximately 5,526 cord blood specimens. He will then return to NICHD three aliquots of 200 microliters of DNA at a concentration of 50ng/uL from each of the approximately 5,526 specimens. This will result in a total of 16,578 DNA specimens that will be available to approved researchers through programs such as NICHD DASH.